Enhancing FLT3 inhibitor efficacy in acute myeloid leukemia with FLT3-ITD

Acute myeloid leukemia (AML), the common type of acute leukemia in adults, is an important health
concern for Veterans due to its high incidence and frequent poor response to treatment. Internal tandem
duplication (ITD) of the fms-like tyrosine kinase 3 (FLT3) receptor tyrosine kinase is present in AML cells of
30% of patients and is associated with poor treatment outcomes. FLT3 inhibitors have activity, but responses
are limited and transient, with rapid development of resistance occurring by diverse mechanisms.
FLT3-ITD causes constitutive FLT3 signaling, which is also aberrant. In addition to activating the
PI3K/AKT/mTOR and MEK/ERK/RAS pathways, which are activated by signaling of wild-type FLT3, FLT3-ITD
activates signal transducer and activation of transcription (STAT) 5, which transcriptionally upregulates the
oncogenic serine threonine kinase Pim-1. Pim-1 contributes directly to the proliferative and anti-apoptotic
effects of FLT3-ITD, and also phosphorylates and stabilizes FLT3, promoting STAT5 signaling in a positive
feedback loop in cells with FLT3-ITD. Cells with FLT3-ITD also exhibit inactivation of the serine/threonine
phosphatase protein phosphatase 2A (PP2A), which has tumor suppressor activity. The transcription factor c-
Myc is transcriptionally upregulated downstream of FLT3-ITD, along with Pim-1, and knockdown of c-Myc or
Pim-1 has anti-proliferative effects in cells with FLT3-ITD. In addition, PP2A and Pim-1 both regulate c-Myc
post-translationally. We hypothesize that concurrent targeting of aberrant signaling pathways will enhance the
efficacy of FLT3 inhibitors and prevent development of resistance to FLT3 inhibitors, and overcome resistance.
Mechanisms of acquired resistance to FLT3 inhibitors include development of point mutations in the FLT3
kinase domain, a FLT3-dependent mechanism, and of RAS mutations - a FLT3-independent mechanism.
Expression of Pim kinases is also further upregulated in cells with FLT3-ITD with FLT3 inhibitor resistance.
Work in our prior VA Merit Award focused on cellular and molecular effects of pan-Pim kinase inhibition in
AML cells with FLT3-ITD. Pim inhibition has little effect by itself, but potentiates the anti-proliferative and pro-
apoptotic effects of FLT3 inhibitors and of chemotherapy drugs in cells with FLT3-ITD. We found that Pim
inhibition enhances induction of apoptosis of AML cells with FLT3-ITD by FLT3 inhibitors in vitro and in vivo
via post-translational downregulation of the anti-apoptotic protein Mcl-1 and its deubiquitinase USP9X. We
subsequently found that post-translational c-Myc downregulation precedes these changes. We also found
that concurrent treatment of cells with FLT3-ITD with PP2A-activating drugs and FLT3 inhibitors causes
post-translational downregulation of c-Myc and Pim-1; and that these effects are mediated by AKT
inactivation-dependent activation of GSK-3 which phosphorylates both c-Myc and Pim-1, enhancing their
proteasomal degradation.
The overall hypothesis of this Merit award proposal is that concurrent treatment with PP2A activating
drugs or Pim kinase inhibitors enhances the efficacy of FLT3 inhibitors in AML with FLT3-ITD, abrogates or
delays development of FLT3 inhibitor resistance, and has the potential to re-sensitize cells with FLT3
inhibitor resistance occurring by diverse mechanisms.
Our Specific Aims are: 1. To test the hypothesis that PP2A-activating drugs and Pim kinase inhibitors
increase FLT3 inhibitor efficacy through GSK-3-mediated post-translational c-Myc downregulation; 2. To test
the efficacy of PP2A-activating drug or Pim inhibitor co-treatment in preventing FLT3 inhibitor resistance; and
3. To determine the efficacy of Pim inhibitor or PP2A-activating drug co-treatment in re-sensitizing AML cells
with FLT3-ITD with FLT3 inhibitor resistance occurring by diverse mechanisms.
The long-term objective is to develop clinical trials, with the ultimate goal of improving outcomes for
patients with AML with FLT3-ITD, a common AML subtype with poor treatment outcome.

Public health relevance
Acute myeloid leukemia (AML) accounts for 80% of adult acute leukemia and has a five-year survival rate of only 25%. It is more common in men and incidence increases with age. AML is associated with military service in specific groups of Veterans. It also develops following treatment for other cancers, including those common in Veterans. This merit award proposal explores approaches to improving treatment for AML with fms-like tyrosine kinase 3 internal tandem duplication (FLT3-ITD), a molecular abnormality present in AML cells in 30% of patients and associated with poor treatment outcomes. The work has the potential to improve outcomes in Veterans who develop this common and unfavorable AML subtype, including following military and medical exposures. The long-term goal is to develop clinical trials of multi-targeting approaches to improving outcomes of patients with AML with FLT3-ITD.